UCSD Integrated Cardiovascular Epidemiology Fellowship

SUMMARY/ABSTRACT
The objective of the T32 funded “Integrated Fellowship on the Epidemiology and Prevention of
Cardiovascular Disease" is to rigorously train physicians and behavioral scientists in epidemiologic and
behavioral research methods focused on preventing cardiovascular diseases by a) providing trainees with an
integrated, comprehensive, and intensive 2-year research training experience in CVD prevention and/or
behavioral medicine, b) linking trainees with highly experienced and dedicated mentors who will supervise the
research experience and evaluate their progress, and c) providing instruction to these trainees on multiple
related components of the research process, including relevant didactic coursework, protection of human
subjects in research, confidentiality requirements, elements of appropriate and unbiased analysis of data, and
finding post-training employment. The program began in 2007 focused on epidemiology and prevention.
During that first funding period (2007 – 2012), we learned that, while all trainees are focused on prevention,
some had an epidemiologic focus while others were more interested in behavioral medicine. In order to
accommodate these different interests, and for the funding period from 2012 – 2017, we changed the structure
of the program by expanding the leadership to two Co-Directors; one with experience in cardiovascular
epidemiology (Criqui) and the other with experience in behavioral medicine (Marcus), while retaining an
Associate Director (Allison). During that funding period, the number of positions was expanded from four to
five (2 predocs and 3 postdocs). During the next [current] cycle (2017 – 2022), the number of trainees
increased to six (2 predocs and 4 postdocs) and the leadership was changed such that Dr. Allison became the
Program Director and Dr. Marcus remained the Co-Director, while Dr. Criqui became the Senior Associate
Program Director. Two years into this funding cycle, Dr. Marcus left the University of California at San Diego
(UCSD) to become the Dean of Public Health at Brown University. To address this change, Dr. Criqui became
the Co-Director. For the proposed funding period (2022 – 2027), and since Dr. Criqui will be retiring, Dr.
Allison will remain the Program Director and we propose Dr. David Strong, who has specific expertise in
behavioral medicine, to be the program Co-Director. To develop the potential future leadership of the program,
we also propose to add two junior faculty: Jan Hughes-Austin as Associate Program Director and Isac
Thomas as Assistant Program Director. Both have completed our T32 program, have active research
programs and are dedicated to mentorship of junior trainees. To achieve the program objectives, faculty for
the proposed program have been recruited from Divisions across the Schools of Medicine and Public Health.
Faculty have also been recruited from the Graduate School of Public Health at San Diego State University
(SDSU), which has teaching programs in both epidemiology and health behavior. Notably, UCSD and SDSU
co-sponsor two joint doctoral programs closely linked to this proposal: Public Health and Clinical Psychology.

Public health relevance
Project Narrative This application to renew an NIH funded (T32) training program focused on the epidemiology and prevention of cardiovascular disease is relevant to public health since heart disease and stroke remain the leading causes of morbidity and mortality in developed countries, and they are becoming significant public health problems in developing countries. Moreover, the causes of these diseases is multifactorial with lifestyle factors, including physical inactivity, poor diet and smoking, accounting for more than 50% of the burden of cardiovascular disease morbidity and mortality. Given this, the proposed training program will prepare pre- and post-doctoral fellows to become researchers who will explore the causes (both medical and behavioral) of cardiovascular disease so that effective prevention strategies can be developed and implemented.